Mentored Research Training in Aging and Surgery (MERITAS)

Although older adults account for 40% of inpatient surgical procedures and for two-thirds of all patients
undergoing the 10 most common operations, their numbers are on the rise, and they suffer significantly worse
outcomes than younger counterparts, critical knowledge gaps exist in how to best care for them and improve
their outcomes. Surgeon-scientists are an important bridge between investigation and bedside patient care.
Unfortunately, the surgeon-scientist workforce is threatened by increasing pressures to generate clinical
revenue, the declining numbers of surgeons with federally funded research programs, and lack of mentorship
for future generations. Research training during surgical residency has been suggested as a solution for
reversing this trend and some have predicted that surgeon-scientists will become “extinct” without such
opportunities. There is a critical need to train surgeons in aging research who will be able to tackle important
research and clinical challenges to meet the growing need for surgery among older adults. We propose the
Mentored Research Training in Aging and Surgery (MERITAS) Program at the Center for Surgery and
Public Health (CSPH) at Brigham and Women’s Hospital (BWH) to train surgical residents in health
services research at the intersection of surgery and aging with a particular focus on frailty, Alzheimer’s
Disease and Related Dementias, Multimorbidity, and Serious Illness. The overall goal of this training
program is to create a diverse community of n=8 superbly trained surgeon-scientists to conduct studies to take
on the mounting research, clinical, and policy challenges to improving care for older surgical patients. The
MERITAS program has three aims: 1) To leverage existing rigorous post-doctoral training infrastructure at
CSPH, BWH, the Longwood Medical Area (Harvard Medical School and the TH Chan Harvard School of Public
Health) and the Boston Claude D. Pepper Older Americans Independence Center to generate resident-led,
hypothesis-driven research from concept to dissemination intersecting surgery and aging under the mentorship
of a multidisciplinary cadre of health services researchers in aging and surgery. 2) To increase access to
rigorous training in health services research in surgery and aging for surgical residents from groups URiM and
clinical training programs lacking resources to support such research training through targeted recruitment and
mentorship. And 3) To launch a community of next-generation health services researchers in surgery and
aging prepared for independent research careers through networking, longitudinal sponsorship and alumni
activities. The program will be co-led by surgeon-scientists Drs. Zara Cooper and Louis Nguyen, and
supported by 14 experienced mentors, with critical input from an Executive Committee and External Advisory
Board comprised of researchers and leaders in surgery, geriatrics, epidemiology, health policy and other key
disciplines. This program will yield a diverse cohort of future surgeon-scientists dedicated to improving the
health and well-being of older surgical patients.

Public health relevance
Project Narrative As growing millions of older adults with frailty, Alzheimer’s Disease and related dementias, multimorbidity and serious illness undergo surgery, significant knowledge gaps remain as how to best care for them and achieve optimal outcomes. Rigorous research training is required to prepare the next generation of surgeon-scientists to take on the clinical, research, and policy challenges ahead, however there are no training programs specifically designed to give surgical residents, including those from under-represented minority groups, necessary skills to conduct high-quality research related to fundamental questions in surgery and aging. We propose the Mentored Research Training in Aging and Surgery (MERITAS) Program based at the Center for Surgery and Public Health (CSPH) at Brigham and Women’s Hospital (BWH) to provide two dedicated years of mentorship and skill development conducting health services research at the intersection of surgery and launch a community of 8 diverse surgeons for productive research careers.